Evaluation of developmental toxicity and ototoxicity of 32 compounds in zebrafish embryos

32 chemicals (18 developmental toxicants, 7 neurotoxicants, 5 unknowns, and 3 negative controls) will be evaluated with a battery of assays in zebrafish embryos. The maximum tolerated concentration will be determined with 5 concentrations/compound (0.1-1000 μM). Developmental toxicity, ototoxicity and compound bioavailability (internal concentration) will be evaluated following compound exposure for 96 hr (n=15).